Machine learning methods for interpreting spatial multi-omics data

PROJECT SUMMARY
The proposed research program aims to develop innovative computational tools for the analysis and
integration of data from emerging spatially-resolved genomic technologies, which have the potential to uncover
the role of interactions with the environment in normal development and disease. Existing analytical tools for
analyzing spatial omics data are limited in their interpretability and are not capable of integrating multi-modal
data.
Leveraging our extensive experience in computational modeling of single-cell data as another
high-dimensional genomic data type, we will design machine learning frameworks in the form of probabilistic
and deep generative models to tackle the analytical challenges of spatially-resolved genomic data and
importantly integrate multiple data modalities. This framework will enable the identification of neighborhood
patterns defined as regions with a unique composition of cell states, from the integration of spatial profiling of
mRNAs, proteins, and histological imaging (Aim 1). We will build on a foundation of modeling gene regulatory
networks to develop the first computational tool for inferring spatially-varying regulation from the integration of
spatial ATAC-seq and RNA-seq (Aim 2). Additionally, we will develop a computational tool for inferring the
spatial distribution of cells with distinct copy number profiles, and their associated gene programs (Aim 3).
We highlight the versatility and generalizability of our computational methods by applying our techniques in
multiple biological systems with our collaborators. These applications will provide novel insights in
understanding the basis of spatial patterns in human and mouse embryonic development, brain organoid
models, as well as disease systems such as neuropsychiatric disorders, glioblastoma and breast cancer. Our
goal is to disseminate our computational toolbox as open-source software to the broader genomics community
to unlock novel insights about the spatial organization of cell types, their interactions, and mechanisms in
various biological systems.

Public health relevance
PROJECT NARRATIVE This proposal seeks to address the unmet need for computational tools capable of analyzing emerging spatial genomic datasets in particular in complex tissues. We aim to develop interpretable and rigorous machine learning models to propel characterization of diverse cell types, their spatial organization and interactions, and their underlying gene circuitry from combining transcriptomic, proteomic, epigenomic and imaging datasets. Our tools will be impactful in understanding the role of the microenvironment and cell-cell crosstalk in a wide range of normal and disease tissue types.